The role of mito-nuclear communication in the adaptation to mitochondrial dysfunction and stress resistance

PROJECT SUMMARY/ABSTRACT
Interactions between mitochondrial (mtDNA) and nuclear (nDNA) genomes are essential for
maintaining mitochondrial and cellular functions. However, an age- and disease-associated increase of
heteroplasmic mtDNA (the presence of different mtDNA haplotypes) creates an inter-genomic mismatch that
perturbs mitonuclear interaction efficiency. Disrupted mitonuclear interaction results in mitochondrial
dysfunction, reduced organismal fitness, and initiation of various stress that has been associated with a
plethora of many human diseases, such as Huntington's disease, Leber's hereditary optic neuropathy, and
type 2 diabetes mellitus. In response to disrupted mitonuclear interactions, cells activate stress response
pathways to remodel gene expression and metabolism, thereby maintaining mitochondrial function and
alleviating cellular stress. However, a detailed molecular understanding of mitonuclear mechanisms linking
activation of stress response pathways for maintaining mitochondrial function and stress resistance has been
understudied, representing a significant knowledge gap. I hypothesize that distinct mismatched mitonuclear
genomes maintain coordination of mitochondrial status with various stress response pathways to alleviate
harmful consequences of suboptimal mitonuclear interactions. To test this hypothesis, we developed a novel
yeast mitonuclear exchange model (cytoductants) by combining more than 100 mtDNA genotypes onto the
same nDNA genetic background, thereby generating an elegant system with various degrees of perturbation in
mitonuclear interaction and altered mitochondrial function. Overall, the main goal of our research is to
mechanistically understand how perturbations in mitonuclear interaction are transduced into biological effects.
My laboratory will build and sustain three research projects to accomplish this goal. We will first test the
hypothesis that understanding mitonuclear communication at molecular level will uncover distinct mitonuclear
responses to perturbed mitonuclear interactions. (Project 1). Secondly, we will identify the crosstalk between
stress response pathways and their downstream effectors in protecting cells from various stress under the
condition of perturbed mitonuclear interaction. Further, we will determine whether a specific type of stressor
determines the specificity of the response or not (Project 2). Finally, with an innovative cell engineering
approach, we will investigate the hypothesis that balancing cellular energy hemostasis can mitigate the effect
of disrupted mitonuclear interaction (Project 3). The proposed research is significant because it will uncover
how cells respond to disrupted mitonuclear interactions to maintain cellular homeostasis. Since many
mitochondrial diseases are carried in heteroplasmy, this basic research into the maintenance of mitonuclear
interaction will likely identify modulators of efficient mitochondrial interaction. It might be targeted
pharmacologically to treat human pathologies associated with mitonuclear dysfunction, such as
neurodegeneration and aging.

Public health relevance
NARRATIVE The proposed research is relevant to public health because the mitonuclear interaction is altered is altered in a number of different diseases including cancer, obesity, neurodegeneration, and aging. Given that the mechanisms regulating mitonuclear interaction are conserved from yeast to humans, understanding this genetic network may allow us to identify new therapeutic targets for potential interventions for human diseases associated with harmful consequences of mitochondrial dysfunction. Therefore, the research is relevant to NIGMS’s mission in supporting basic research that increases understanding of biological processes and laying the foundation for advances in disease treatment.